METABOLIC INTERVENTION IN PATIENTS WITH HEART FAILURE AND ISCHEMIC HEART DISEASE

The purpose of this study is to determine the effects of sodium dichloroacetate (DCA) on the heart's pumping ability in patients with congestive heart failure or with ischemic heart disease.